Novel Statistical Models for Intensive Longitudinal Analyses of Cancer Control Behaviors

PROJECT SUMMARY
This project will develop, test, apply, and disseminate multilevel statistical models and software for estimating
effects of intraindividual means, variances, slopes generated from multi-burst and continuous ILD designs to
predict cancer control behaviors and outcomes. Cancer remains a leading cause of mortality. Approximately
42% of new cancer cases in the U.S. are viewed as potentially avoidable including 19% caused by smoking and
18% caused by excess body weight, physical inactivity, excess alcohol consumption, and poor nutrition.
Intensive Longitudinal Data (ILD) methods, which collect many assessments captured at high density on a micro-
timescale (e.g., seconds, minutes, hours) using real-time data capture methodologies (e.g., Ecological
Momentary Assessment [EMA] and accelerometry), offer enormous opportunities for insight into the dynamic
nature of cancer control behaviors and outcomes. In ILD studies, it is common to have hundreds to thousands
of observations per subject, and this allows us to model intraindividual parameters comprised of time-varying
variables such as means (e.g., how unhappy is a subject, on average, across occasions?), variances (e.g., how
erratic is a subject’s mood across occasions?), and slopes (e.g., is a subject’s mood related to feelings of energy
across occasions?). In our prior work, we developed a software, called MixWILD, consisting of a series of two-
stage multilevel statistical models testing the effects of intraindividual means, variances, and slopes on time-
varying and subject-level outcomes. The next generation of ILD studies has begun to use multi-burst (e.g.,
multiple day EMA periods interspersed with days with no assessment) and continuous (e.g., 24-hour/days per
week smartwatch accelerometry) measurement designs, allowing the entire study to extend across months or
years. However, available data analysis techniques cannot address common substantive questions that arise
with multi-burst and continuous ILD designs such as does momentary mood variability increase across a year?
Also, do month-to-month increases in momentary mood variability predict declines in sleep duration over a year?
To address these gaps, we will develop multilevel models capable of (Aim 1) jointly estimating how within-burst
means, variability, and slopes differ between bursts and/or subjects, (Aim 2) testing predictors (either occasion,
burst-, person-level) of how within-burst means, variability, and slopes differ between bursts and/or subjects, and
(Aim 3) testing whether random effects from Aim 1 predict subject- and burst-level cancer control outcomes. We
will test and apply these statistical features by conducting secondary analyses of data from a multi-burst ILD
study of cancer control behaviors and outcome, which conducted mobile sensing, EMA, and accelerometry from
246 emerging adults (ages 18-29) across 12 months. We will also develop, test, and disseminate a stand-alone
software with GUI capable of running these statistical models to be used by applied behavioral and social science
researchers. The methods to be developed can easily generalize to a variety of other disease areas such asthma,
disordered eating, suicide prevention, HIV risk, medication adherence, and environmental exposures.

Public health relevance
PROJECT NARRATIVE This project will develop, test, apply, and disseminate new features for multilevel statistical models and software to estimate effects of intraindividual means, variances, slopes of time-varying variables on cancer control outcomes using intensive longitudinal data collected over much longer periods than the typical single burst design. The results will make notable methodological and substantive contributions for the analysis and application of intensive longitudinal data cancer control research. Given the enormous health burdens imposed by cancer, such information could be of significant value to efforts to improve public health.